Critical Analysis of Data-Rich Networks for Biomedical Scientists in Training.

Advanced high-throughput technologies have transformed biomedical research into a data-intensive discipline,
in which the rate of data collection and the complexity of data sets have exceeded the ability of classically
trained scientists to extract and assimilate meaningful information. Today, This proposal is motivated by the
need to build this critical workforce of biologists armed with cross-disciplinary training in computational,
quantitative and analytical realms to harness the power of ‘Big Data’ in biomedical sciences and recognition
that demand for these trained scientists represents a unique opportunity to promote diversity, equity, and
inclusion in science. This training program at the University of Nebraska Medical Center (UNMC) will be
administered by the Department of Genetics, Cell Biology and Anatomy, a campus leader in medical and
graduate teaching that hosts key faculty serving as directors for data-rich core facilities such as next-
generation sequencing, bioinformatics and systems biology, and research information technology. The
proposed two-year training program derives from the natural synergy of this in-house expertise with two
department sponsored pre-doctoral graduate programs in Molecular Genetics and Cell Biology (MGCB) that
focuses on biological and disease mechanisms using high-throughput -omics approaches and Bioinformatics
and Systems Biology (BISB), which emphasizes on novel algorithm development and computational and
statistical training to advance design and analysis of big data experiments. The proposed program requests
funding for three pre-doctoral traineeships in the first year and six in the subsequent years with a two-year
trainee rotation. Participants will be selected concurrent with application to UNMC graduate programs and
matriculating students will receive training from preceptors representing 38 laboratories in 14 basic science
and clinical departments at UNMC and our sister campus, University of Nebraska Omaha. Trainees will take
courses in bioinformatics, statistical analysis, biological networks, and research design and scientific thinking to
provide a common skill set and language for interdisciplinary research. Workshops, seminars, and a team-
based project will develop essential skills for collaborating in a ‘Big Data’ world and presenting analyses of
complex data sets to diverse audiences as well as promote a sense of belonging, a key factor in achievement
and retention of underrepresented minority students. The program directors are counseled by an internal
advisory committee composed of faculty with experience in student mentoring and directing training programs,
and a team of external advisors with experience developing T32 and other training programs. Collectively, this
hierarchy of advisors and mentors will ensure that the program produces the next generation of leaders in ‘Big
Data’ biomedical research, which are essential to workforce development in Nebraska and the surrounding
region that include several IDeA states.

Public health relevance
Project Narrative: This predoctoral training program is designed to train the next generation biomedical researchers, hence it is directly relevant to public health. The mission of this program is to address the critical need to equip experimental biologists with quantitative and analytical capabilities, effective communication, and leadership skills in the data-rich field of biomedical sciences. Trainees graduating from this program are expected to adopt well to the rapidly changing landscape of big data in experimental research and thrive well as biomedical scientists.